Transcriptional regulation of photoreceptor identity and function

PROJECT SUMMARY/ABSTRACT
Vision loss caused by the death of photoreceptors is a leading cause of irreversible
blindness worldwide, yet therapeutic options remain limited. For this reason, the NEI’s Retinal
Disease Program has identified the development of strategies for the treatment of retinal
degenerations as a core program goal. Recently, several laboratories have derived
photoreceptors from stem cells, making cell-replacement therapies particularly promising.
Additionally, important advances have been made into manipulations that could stimulate retinal
regeneration from the retinal Müller glia. The critical barrier for the success of such therapies is
to understand the factors required to direct fate decisions in progenitors towards fully
differentiated cell subtypes that are also capable of properly rewiring into retinal circuits. Although
key transcription factors have been identified as essential for generating retinal cell classes, the
target genes required to generate each retinal cell subtype are still undetermined.
TBX2 is a central transcriptional regulator of all photoreceptor subtypes and is highly
conserved across vertebrates. Our main hypothesis for this proposal is that retinal progenitors
express TBX2 to repress the identity of photoreceptor subtypes that are not UV cones through
two different mechanisms, and our main goal is to identify these two roles. Three Specific
Aims are proposed:
Specific Aim 1 will test the hypothesis that tbx2a and tbx2b have subdivided functions and
their roles in generating photoreceptor subtypes are different.
Specific Aim 2 will identify candidate factors downstream of TBX2 important for the generation
of photoreceptor subtypes.
Specific aim 3 will test the hypothesis that differences in Tbx2a and Tbx2b function are caused
by differences in the repression domain.
At the successful completion of this project, I will have identified the subdivided functions
of tbx2a and tbx2b and subsequent targets to generate and maintain photoreceptor subtypes.
This proposal benefits from the experimental accessibility of the retina and our deep knowledge
of retinal cell types and circuits, but our approach has the potential to impact the study of other
neuronal degenerative diseases. In addition to my proposed research, I designed a holistic
training plan that will help me advance toward my goal of leading an independent research lab.
The work planned for the F31 award period will be valuable in terms of both research and training
opportunities.

Public health relevance
Project Narrative Retinal degenerations are a major cause of blindness in developed countries, producing significant disability and burden to public health; developing therapies is a key goal for the National Eye Institute. The most promising (and still experimental) therapies, aimed at replacing the lost photoreceptors by either stimulating regeneration of the retina or by cellular transplantation, are still unsuccessful and have exposed gaps in our knowledge about the mechanisms that control the generation of cellular diversity in photoreceptors. This proposal aims to discover and study such mechanisms, with the aspiration to apply this knowledge to the development of therapies for retinal degenerations.